Regulation of stem cell fate by FOXO and RNA binding proteins

Project summary
A fundamental gap exists in the understanding of how developmental pathways are regulated to maintain
stem cell multipotency during extended periods of quiescence, or non-division. The FOXO family of
transcription factors are key regulators of stem cell maintenance and quiescence. However, the
mechanisms by which FOXO proteins impact developmental pathways to control cell fate are poorly
understood. This application capitalizes on the power of the C. elegans system to address the
mechanisms by which the single FOXO ortholog, daf-16, regulates conserved developmental pathways to
preserve stem cell multipotency during quiescence. To model stem cell quiescence, we will use the
quiescent dauer larva stage, adopted midway through development in response to adverse environmental
conditions. This approach is innovative because the C. elegans system allows us to study quiescent,
multipotent cells in vivo at single cell resolution, complementing mammalian studies. The long-term goal of
this lab is to decipher the mechanisms that promote multipotency during dauer. Epidermal seam cells, the
stem cell model, are multipotent and undergo a characteristic pattern of self-renewing cell divisions at
each larval stage until differentiating at adulthood. During dauer, seam cells are quiescent and active
mechanisms maintain multipotency. Preliminary data establish that during dauer, FOXO/daf-16 blocks
adult cell fate by positively regulating the expression of three genes that encode RNA-binding proteins
(RBPs). The orthologs of these RBPs regulate the proliferation and function of stem and progenitor cells in
flies and mammals. The objective of this application is to unravel the mechanisms by which FOXO/daf-16
acts via RBPs to regulate adult cell fate during the quiescent dauer stage. Three specific aims are
proposed to meet this objective. 1) Determine the genetic relationship between FOXO/daf-16 and RBPs.
Loss-of-function and gain-of-function experiments will establish the regulation of RBPs by FOXO/daf-16, a
novel mechanism to control cell fate. 2) Identify direct RBP targets that block adult cell fate during
quiescence. Direct mRNA targets of RBPs will be identified by iCLIP. Functional testing will determine
which targets are involved in the regulation of seam cell fate. Together these experiments will elucidate
the connection between FOXO/daf-16-regulated RBPs and adult cell fate. 3) Dissect the transcriptional
regulation of an adult cell fate marker during quiescence. Preliminary data establish that during dauer,
FOXO/daf-16 and the three RBPs block expression of a transcriptional reporter of an adult-specific gene,
widely used to mark adult cell fate. Promoter dissection and functional testing of candidate transcription
factors will decipher the quiescence-specific regulation of a key adult cell fate marker. The proposed work
is significant because it will illuminate how the regulation of developmental pathways is coordinated with
the regulation of quiescence in multipotent cells.

Public health relevance
Project Narrative The proposed research is relevant to human health because the elucidation of evolutionarily conserved mechanisms that promote multipotent cell fate during quiescence is expected to advance the field of stem cell biology. The proposed work will illuminate a novel pathway involving FOXO transcription factors and RNA-binding proteins that are conserved from C. elegans to mammals. These factors are key regulators of stem cell fate across species. The project is relevant to the mission of NIH and NIGMS because it is expected to provide fundamental knowledge about stem cell biology and to lay the foundation for clinical applications.